Mol: An interactive learning platform to address difficult concepts in organic chemistry

In this NIH Phase I SBIR project we propose to develop and evaluate a proof-of-concept for Mol, a mobile STEM game to address difficult to learn topics in organic chemistry. Our first module will focus on stereochemistry, a notoriously challenging concept facing nearly 2 million undergraduate students each year who are pursuing a healthcare career, and another 1 million biology and chemistry students. Significance: Organic compounds and their interactions constitute the very foundation of life. The relevance of organic chemistry to medical research and practice is profound. About half of medicinally-used pharmaceuticals, toxins, and illicit drugs, require chiral centers for their activity. The increasing relevance of organic chemistry to medicine means that the integration of organic chemistry is more and more important in modern health-related education. Interactive media provides a potentially transformative technology for education. The intrinsic appeal and intuitive nature of interactive apps to the millennials and the as-yet-unnamed post-millennial generation makes them a powerful medium for learning, and interactive apps are beginning to take their place in classrooms as a complement to teacher-based lectures. Innovation: The Mol mobile app would provide a powerful approach to enable student success, learning about the 3D shapes and properties of organic molecules and how these relate to real-life health applications. Gameplay mechanics could include spatial puzzles where the player must correctly identify chiral centers on rotating 3D structures, time trials challenging the player’s ability to quickly match the corresponding structure with the nomenclature presented, and a mode promoting the manipulation of 3d models to determine stereoisomerism, and build-your-own stereoisomer. Approach: Our team has extensive knowledge in educational game development, notably with the NIH-SEPA- sponsored Meta!Blast. Developed with Unity3D, Meta!Blast is now used in college classrooms and in informal education settings, including being incorporated as a major component of the core Biology Lab at Iowa State University. It’s being evaluated in several biology classroom settings at institutions across the country; one example is at Chaffey College, Rancho Cucamonga, California, a two-year community college with a high proportion of Hispanic students and veterans. We are confident this experience can be extended to the project outlined in this proposal. Each aspect of Mol will be developed with user-input using a rapid iteration approach. Bi-weekly discussions and formative evaluations will ensure the creation of a product that is engaging, fun, relevant, usable, and educational. This will be followed by a larger summative evaluation and data analysis. Commercialization: Through our experience in the rigorous NSF I-Corps program, we believe that following a successful Phase I and Phase II effort, we have the knowledge and support to address the large opportunity in this market segment. A commercially viable app would be distributed to Android and iOS platforms through Google Play and the Apple App Store, respectively. As observed in our customer discovery process, students indicated a significant factor in their adoption of new learning materials would be from a recommendation or requirement by their instructor. As such, a key element in our marketing strategy is to cultivate relationships with chemistry instructors and view them as demand creation partners.

Public health relevance
Project Narrative Organic compounds and their interactions constitute the very foundation of life. Driven by new technologies of analytical chemistry and nanobiology, organic chemistry now provides the basis for the fields of toxicology, pharmacodynamics (the effect a drug has on the body), pharmacokinetics (how the body metabolizes a drug), and rational drug design (using understanding of a biological target to design new drugs). Our proposed STEM game aims to address the challenges undergraduate students face when learning organic concepts.